Multiplexed Quantification of the Protein Poly-ADP-Ribosylation Landscape in C9ORF72-ALS/FTD

Project Summary PARP1 is a nuclear protein that is critically involved in cell stress responses. Its main
enzymatic function is to catalyze a protein posttranslational modification (PTM) known as Poly-ADP-ribosylation
(PARylation). In response to genotoxic stress, PARP1 binds to nicked DNA and is rapidly activated, resulting in
the synthesis of a large number of PARylated proteins and initiation of the DNA damage repair (DDR)
mechanisms. Recent evidence suggests that PARylation serves as a death signal in neurons. Importantly,
genetic deletion or pharmacological inhibition of PARP1 offers profound protection against brain dysfunction in
the animal models of many dementias, including Alzheimer’s disease, Parkinson’s disease, amyotrophic lateral
sclerosis/ALS and frontotemporal dementia/FTD. C9orf72 repeat expansion is the most common genetic cause
of both amyotrophic lateral sclerosis and frontotemporal dementia. PARP1 is a common disease modifier of
C9orf72-ALS/FTD, the inhibition of which (by pharmacological and genetic approaches) ameliorates
neurodegeneration in various models of C9orf72-ALS/FTD. Furthermore, recent studies have shown that
increased PARylation is a common pathological feature of ALS/FTD regardless of the underlying genetic causes.
Despite these findings, the PARylation landscape in C9orf72-ALS/FTD is poorly defined, and the underlying
mechanism by which deregulated PARylation contributes to C9orf72-ALS/FTD is elusive. To address this, we
will leverage our published work and the extensive experience of my lab. PARylation is a notorious PTM for
mass spectrometrists, because of its labile and heterogenous nature. We recently were able to overcome these
challenges, and develop a large-scale mass spectrometric approach towards comprehensive characterization of
the Asp- and Glu-PARylated proteome. Furthermore, we have elucidated the site-specific function of the
PARylation events on many important signaling proteins. Based on these results, we will develop a “bar-coding”
system for the multiplexed PARylation proteomic analyses. Using this approach, we will define, in a global,
quantitative and site-specific manner, the PARylation landscape in C9orf72-ALS/FTD (Aim 1). Then we will
generate the global protein expression profiles of C9orf72-ALS/FTD induced pluripotent stem-cell-derived
neurons (iPSNs), and identify the cell-specific PARylation events that are driven by cell-specific expression
patterns vs. cell-specific regulatory mechanisms (Aim 2). Finally, we will deploy bioinformatic tools to identify the
potentially functionally important PARylated proteins. These high priority hits will be subject to biochemical and
cell biology assays to understand their roles in C9orf72-ALS/FTD. We will also design and generate a web portal
for the dissemination of the quantitative proteomic results (Aim 3). The information garnered from these studies
will provide a fundamental understanding of the role of PARylation in C9orf72-ALS/FTD, paving the way for
targeting this pathway for the treatment of C9orf72-ALS/FTD, and more broadly, the other related dementias.

Public health relevance
Project Narrative Although aberrant PARP1 activation is linked to many neurodegenerative disorders (e.g., C9orf72-mediated amyotrophic lateral sclerosis and frontotemporal dementia or C9orf72-ALS/FTD), how protein Poly-ADP- ribosylation (PARylation) signaling contributes to the pathogenesis of these dementias is poorly understood. In this proposal, we will develop a multiplexed proteomic approach for the global, quantitative and site-specific characterization of the Asp-/Glu-PARylated proteome in C9orf72-ALS/FTD. Combined with functional studies, we will elucidate how deregulated protein PARylation events cause neurodegeneration in C9orf72-ALS/FTD.